ANALYSIS OF AN EVALUATION OF THE ZUNI WELLNESS CENTER

The purpose of this study is to determine if the Zuni Indians who utilize the exercise programs at the Wellness Center and/or exercise independently should have less risk for developing Type 2 Diabetes compared to individuals who exercise infrequently.